Computational approaches to single molecule force spectroscopy

DESCRIPTION (provided by applicant): A molecular understanding of the way proteins and RNA fold and how they respond to each other holds the key to describing their functions and the ability to design biological molecules with novel functions. Spectacular advances in experiments, that manipulate biomolecules at the single molecule level using mechanical force, are providing an unprecedented picture of the folding landscapes of proteins, RNA, and ligand-protein complexes. Computer simulations that can be done under conditions that are similar to those used in experiments are required to extract molecular details of the underlying biophysical processes from measurements. We describe novel theoretical and computational tools that are not only integral to the understanding of the experiments but are also useful in predicting their outcomes over a range of conditions that are difficult to explore in the laboratory. Using computational methods, we are poised to make substantial progress in quantitatively describing the folding mechanisms of proteins and RNA and the interactions between cell adhesion molecules and their cognate ligands. In particular, the proposed research will offer insights into the molecular basis of elasticity of Green Fluorescent Protein and Lysozyme and the dependence of folding routes in RNA and proteins on the precise way force is applied. Applications are also planned to explore mechanical stability of Ubiquitin in the presence of crowding particles. The work on the response of the complex between the cell adhesion molecule PSelectin and the ligand is intended to provide molecular details of the unusual enhancement of the lifetime of the complex at low forces. Our studies will lead to a global framework for interpreting a wide range of single molecule experiments and will prove essential in the design of new experiments that can probe biophysical processes under cellular conditions. The conceptual progress and applications to a number of cutting edge problems that is expected from the proposed researches will lead to a substantial advance in our understanding of the response of biological molecules to force - which is pivotal to a number of in vitro and in vivo problems.

Public health relevance
PUBLIC HEALTH RELEVANCE: Understanding how RNA and proteins fold and interact with each other holds the key to describing their functions. The proposed research will give a molecular view of the underlying mechanisms of these processes at the single molecule level. The studies will give us insights into diseases linked to misfolding and the biophysical basis of response of cell adhesion proteins to inflammation and tissue injury. Project Narrative Understanding how RNA and proteins fold and interact with each other holds the key to describing their functions. The proposed research will give a molecular view of the underlying mechanisms of these processes at the single molecule level. The studies will give us insights into diseases linked to misfolding and the biophysical basis of response of cell adhesion proteins to inflammation and tissue injury. __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS Long Term: Single molecule experiments that use mechanical force as a probe are beginning to yield unprecedented profiles of the complex folding landscape of biomolecules. In order to reliably estimate the characteristics of their energy landscapes it is necessary to combine the experimental measurements (the force extension curves, the mechanical folding trajectories, force or loading rate dependent unfolding and refolding rates) with sound theoretical models and simulations. We have pioneered the development of theoretical and computational tools to predict the outcomes of single molecule experiments, and have applied them to simple systems. Building on these studies our long term goal is to provide a quantitative framework for predicting the response of proteins, RNA, and cell-adhesion complexes that are subject to mechanical force. Aim I: Pathways and kinetic barriers in the unfolding of proteins and RNA. Depending on the protocol (force-clamp or stretching at constant loading rates) single molecule force spectroscopy typically yields force (f) as a function of extension time-dependent changes in the end-to-end distance of the system of interest. Molecular details of the structures that are explored by the biomolecule subject to f requires simulations that can be carried out under conditions that closely mimic the ones used in experiments. We will study the changes in the folding landscape of GFP and lysozyme to clarify the unusual observations in GFP that unfolding forces vary dramatically as the pulling direction is altered. In addition, we will also probe the unfolding routes of RNA molecules (focusing on riboswitches and ribozymes) as a function of f. These studies will provide insights into the structural changes upon folding, which are difficult to obtain from experiments alone. Aim II: Refolding of proteins and RNA upon force-quench. Refolding of proteins and RNA using f can be initiated from arbitrary regions of the energy landscape that are inaccessible in conventional experiments. The pathways explored upon force quench should depend on the initial stretching force (fS), the final force quench force (fQ), and the protocol used to reduce the force from fS to fQ). We will explore in quantitative detail the variations in the force-quench refolding of proteins and riboswitches as a function of fS and fQ and how the pathways change depending on the protocol used in quenching the force. We will use in silico implementation of force correlation spectroscopy to determine the nature of collapsed structures of proteins and RNA. The conceptual outcomes from these studies will be crucial in interpreting the diverse set of experiments on a number of systems. Aim III: How do linkers modulate the folding landscape of biomolecules? In force-clamp LOT experi- ments linkers, usually long DNA molecules, are attached to the ends of the protein or RNA of interest. The goal is to infer the folding landscapes without handles from measurements with handles! It is, therefore, important to describe how the dynamics associated with the linkers affect the force-dependent transitions in RNA or proteins. We propose molecular simulations of RNA (riboswitches and subdomains of Tetrahy- mena ribozyme) which have well characterized intermediates and proteins (RNse H and Ubiquitin) that have been studied using single molecule force spectroscopy. Aim IV: Catch and slip bonds in P-Selectin-PSGL-1 complex. Leukocyte tethering and rolling along endothelium, in response to inflammation, is mediated by a class of cell -adhesion proteins that belong to the lectin family. Recent AFM experiments showed that upon application of force P-Selectin bound to ligands makes a transition from catch bond (lifetime increases at low forces) to the slip bond (the expected decrease in the lifetime of P-selectin-ligand complex). We will develop molecular models to explore the structural basis of the origin of the catch bond. We will also explore, using a combination of simulations of all atom and coarse-grained models, whether the novel paradigm of catch bonds are also observable in other complexes involving cell adhesion molecules.